NeoChip for specific and rapid identification of congenital CMV and neonatal HSV infections on minimal sample volume

Project Summary
Congenital cytomegalovirus (cCMV) and neonatal herpes simplex virus (nHSV) impose major health threats on
neonates. Although CMV and HSV are lifelong infections with periods of latency and reactivation, most maternal
infections remain undiagnosed due to nonspecific or absent clinical symptoms. In the United States, a child is
permanently disabled by cCMV infection every hour, even though 9 of 10 infants are asymptomatic after birth and
remain undiagnosed. Invasive nHSV, on the other hand, is a rare neonatal infection that presents with a broad
range of clinical symptoms, including those that may be life-threatening. Viral culture and DNA detection by
polymerase chain reaction (PCR) have become the “Gold Standard” for the diagnosis of cCMV and nHSV infection,
despite poor sensitivity of PCR assays in neonates and time consuming culture techniques (up to 5-7 days).
Universal genotyping of pathogen genomic sequences using High Resolution Melt (U-HRM) provides a simple,
low cost, rapid, and modern alternative to viral cultures and PCR techniques. By measuring the fluorescence of
an intercalating dye as PCR-amplified pathogen DNA or RNA fragments are heated and disassociate, sequence
defined melt curves, or “fingerprints”, are generated with single-nucleotide resolution in a closed-tube reaction.
These unique microbial “fingerprints” are then automatically identified and quantified using machine learning
technology, with an accuracy of 99-100% on minimal blood volume (1 mL), in a platform called NeoChip. Presently,
we have established unique signature melt curves for 40 bacterial species and antimicrobial resistance genes that
commonly infect neonates. Additionally, NeoChip has been expanded to distinguish individually amplified melt
curve signatures for multiple pathogen identification and quantification, as required for polymicrobial infection.
In this proposal, we will build out NeoChip’s comprehensive database by incorporating clinical strains of CMV
and HSV with actionable antiviral resistance genes. Because NeoChip identifies variances in nucleic acid
sequences, individual differentiation and quantification of CMV and HSV strains are possible. We will also translate
the NeoChip for specific and rapid diagnosis of cCMV and nHSV infection in a large prospective clinical study of
pregnant women and their offspring(s), as well as directly compare the platform to standard quantitative nucleic
acid test (QNAT) assays, IgG/IgM antibody testing, and clinical outcome measures for statistical concordance
(predictive value). Finally, we will validate and translate NeoChip for cCMV detection and clinical correlation using
dried blood spot (DBS) samples for incorporation into standard universal newborn screening programs. NeoChip’s
goal is to provide an accurate and valid test for the timely diagnosis of pathogen etiology (viral, bacterial, and
fungal) in a single test with efficacy on broad tissue matrices and capacity to inform microbial resistance, thereby
facilitating early administration of targeted antimicrobials and therapeutics. This proposal directly addresses the
funding call by applying a multidisciplinary approach to address the biomedical challenges of rapidly and accurately
diagnosing cCMV and nHSV to facilitate disease prognostication and early therapeutic or intervention programs.

Public health relevance
Project Narrative NeoChip combines real-time PCR, digital High Resolution Melting (dHRM) of DNA and RNA, and machine learning to create unique “fingerprints" for microbes and antimicrobial resistance, allowing for faster and more precise detection of pathogen(s) causing neonatal infection. This project will build out NeoChip’s melt curve database to include clinically relevant strains of cytomegalovirus and herpes simplex virus infections, while concordantly assembling updated epidemiologic timelines and prevalence of perinatal CMV and HSV transmission. Our goals are to validate NeoChip for the rapid and specific diagnosis of congenital CMV and neonatal HSV infection on multiple tissue matrices and translate the NeoChip platform for incorporation into standard universal newborn screening for the diagnosis of congenital cytomegalovirus on dried blood spot samples.